Vascular Pyruvate Kinase M2 in Hypertension

Hypertension is the most significant health burden for society in terms of economic and health costs due to the
increased risk for cardiovascular disease (CVD) such as myocardial infarction and stroke. Patients with
hypertension have significantly greater risks for cardiovascular mortality and morbidity compared to age matched
normotensive subjects, even when the patient’s blood pressure is controlled with medication. Therefore, the
long-term goal of our application is to investigate the core mechanism of vascular remodeling associated with
hypertension so that an effective add-on therapy can be explored for patients with hypertension. Metabolic shift
to glycolysis has been recognized in many types of CVD including hypertension. However, limited information
is available regarding the types of cells influenced, if it contributes to hypertension or remodeling, as well as
critical mechanisms involved. The renin-angiotensin system is considered to play a central role in hypertension
as well as the associated tissue/cell phenotypes including ER stress. While the RAS affects a variety of cells
and hypertension demonstrates a complex pathophysiology, our preliminary data with vascular smooth muscle
cell (VSMC) AT1a receptor deficient mice have demonstrated a critical role of VSMC signaling in angiotensin II
(AngII)-dependent vascular remodeling. Accordingly, in this application, we will explore the essential glycolytic
enzyme pyruvate kinase M2 (PKM2) activation in VSMC via AngII that uniquely mediates vascular remodeling
and hypertension involving alterations in conductance as well as resistance arteries. Based on promising
preliminary data, we propose a central hypothesis that the VSMC PKM2 mediates hypertension and vascular
remodeling in conductance and resistance arteries, which likely involves both metabolic and non-metabolic
effects via its pyruvate kinase and specific protein kinase activities. Three specific Aims are proposed to explore
the vascular mechanisms and the relevance of their signal communication utilizing two distinct models of
hypertension as well as aortic VSMC and fibroblasts in vitro.
Aim 1 will study involvement of PKM2 activation in VSMC in hypertension and vascular remodeling. Aim 2 will
study novel mechanisms of how PKM2 activation in VSMC, glycolysis dependently and independently, mediates
hypertension and vascular remodeling. Aim 3 will explore VSMC-to-fibroblast communication in hypertensive
vascular fibrosis via VSMC PKM2 mediated secretome as well as lactate shuttle.
To study the cell type and mechanism by which PKM2 is involved in hypertension and hypertensive vascular
remodeling, we will utilize genetically or pharmacologically altered mice infused with AngII. In addition, to
enhance translational relevance we will utilize spontaneously hypertensive rats (SHR) as a model for human
essential hypertension with pharmacological manipulations against PKM2. Accomplishment of the proposal will
yield significant advancement of our knowledge regarding the mechanisms leading to the development of
hypertensive vascular remodeling and provide future translational research leading to new therapies.

Public health relevance
Narrative Hypertension is a significant cause of death and disabilities associated with cardiovascular diseases. No sufficient pharmacological treatment has been established for hypertension risks and complications such as vascular fibrosis. We propose rodent models to test our hypothesis that glucose metabolism in vascular cell types form a core mechanism which contributes to vascular diseases associated with hypertension.